THE PURPOSE OF THIS TASK ORDER IS TO MAINTAIN AND ENHANCE THE NIDDK BIOREPOSITORY ROUTINE OPERATIONS TO FACILITATE BIOSPECIMEN UTILIZATION FOR NEW SCIENCE AND BROAD SHARING ACROSS THE RESEARCH COMMUNI

THE PURPOSE OF THIS TASK ORDER IS TO MAINTAIN AND ENHANCE THE NIDDK BIOREPOSITORY ROUTINE OPERATIONS TO FACILITATE BIOSPECIMEN UTILIZATION FOR NEW SCIENCE AND BROAD SHARING ACROSS THE RESEARCH COMMUNI